Strategies to Enhance Produce Safety on Virginia Farms for Implementation of FDAâs Produce Rule

Project Summary Project Title: Strategies to Enhance Produce Safety on Virginia Farms for Implementation of FDA’s Produce Safety Rule Project Description: We intend to develop a plan to implement the FDA’s Produce Safety Rule. This project will be a collaborative effort between FDA, the Virginia Department of Agriculture and Consumer Services and the Virginia Polytechnic Institute and State University. This plan will include education and training for produce farmers covered under the rule, as well as implementation of a regulatory program which will include regulator training. Project Goals: The proposed project will develop a strategic plan for alignment of Virginia’s regulations and activities with FDA’s Produce Safety Rule. Goals include establishing an inventory of covered produce farms, providing farmers with education of, and training on, the Produce Safety Rule, completing an assessment of Virginia’s regulatory authority for produce safety and the resources needed to develop a successful program, and implement the program. Expected Outcomes: We believe that the partnerships and strategic plans that will emerge from the work outlined in this proposal will create a federal-state relationship which will leverage the existing expertise, knowledge and resources of the Virginia Department of Agriculture and Consumer Services and the Virginia Polytechnic Institute and State University which will result in consistent and successful on-farm inspections. Project Objectives: 1) Develop and maintain an inventory of produce farms covered under the rule, including a mechanism to share the data with the FDA. 2) Determine resources needed to conduct activities under a state produce safety rule that has been aligned with FDA’s Produce Safety Rule (identify metrics & develop models for training, technical support/assistance, information technology, inspection/compliance activities). 3) Develop and implement a plan that includes educating producers on produce safety and providing regulatory oversight of the farming of covered produce. The plan will include on-farm inspections, sampling, enforcement, training, education and technical assistance. Budget: $500,000 for year one, $725,000 for year two, $755,000 for year three, $770,000 for year four and $875,000 year for five, totaling $3,625,000 for the five year grant period.

Public health relevance
PROJECT NARRATVE This Virginia Department of Agriculture and Consumer Services project entitled “Strategies to Enhance Produce Safety on Virginia Farms for Implementation of FDA’s Produce Rule” is intended to establish a produce safety regulatory program to address the growing, packing, holding and dissemination of produce grown on farms and that will encourage the safe production of fruits and vegetables and promote understanding and compliance with the FDA’s Produce Safety Rule. To establish the program, the Department will:  Obtain state legal authority to conduct inspections, collect samples, and take enforcement action relating to compliance with on-farm produce safety requirements, and will adopt the FDA’s Produce Safety Rule to regulate these farms.  Hire a Produce Program Supervisor who will assist the Agency with drafting a strategic plan that includes goals and milestones for developing a program to implement FDA's Produce Safety Rule and identifying the resources needed for implementation of the program, and  Utilize the strategic plan to implement a produce safety program.  Contract with Virginia Tech to provide outreach to the farming community and to provide the needed education and training regarding compliance with the new rule. These four goals will significantly advance a national integrated food safety system and effectively fulfill the requirements of the Food Safety Modernization Act .